Care Coordination and Outcomes for High Risk Patients: Building the Evidence for Implementation

Abstract
Background: Care coordination is essential to improve patients’ access to healthcare, clinical outcomes,
enhancing patients experience, increasing provider satisfaction, and decreasing or maintaining costs, yet
appears to be most successful for those with complex care needs. While the VA’s established primary care
model, the Patient Aligned Care Team (PACT) has proven effective in increasing Veterans’ experience and
trust while decreasing costs, many high need, high risk Veterans lack support for their complex clinical
and psychosocial needs that impacts their health care use, outcomes and costs. Two major VA
initiatives led by the Offices of Nursing Service (ONS) and Care Management and Social Work (SW), and the
Office of Community Care (OCC) intend to address this gap with initiation of new care coordination needs
assessment (CCNA) tools to match Veterans with the right level of care coordination and services in 2019. Yet,
the CCNA tools and organizational processes have not been evaluated.
Significance: Evaluation and implementation of effective care coordination practices are a high priority for the
VA and is the focus of two major national initiatives to address MISSION Act access to care goals.
Innovation/Impact: We will leverage ongoing initiatives, using routinely collected CCNA data, supplemented
with health care use data, and Veteran and provider perspectives to systematically evaluate care coordination
needs assessment tools, practices, and impacts on Veterans’ services received, outcomes and costs.
Specific Aims: We will build evidence about the CCNA, processes, and outcomes for high need, high risk
Veterans seeking VA covered healthcare at VA facilities and community sites. Our aims are to:
1. Characterize and compare the relationship between Veteran needs assessment, services received, health
outcomes and costs for Veterans exposed to CCNA with a matched comparison group.
2. Survey and compare Veterans about their experience with care coordination services, integration with other
healthcare services, and perceived health impacts.
3. Conduct formative evaluation to assess provider perceptions at early adoption VA sites about CCNA tools
and processes related to determinants of innovation diffusion, care integration, and to inform and conduct a
broader survey of providers.
Methodology: We will use an organizational theoretical approach including care coordination and innovation
diffusion frameworks to guide our research and employ an observational design using quantitative and
qualitative methods. Veterans treated at early adopter sites beginning in 2019 and categorized as needing
complex care based on the CCNA will be compared to matched Veterans using multiple data sources. Data
sources will include Veteran CCNA from the CC/ICM and OCC sites; CDW, VA Community Care, Consult
Toolbox, Medicare, vital status, and cost data. Survey data will be collected from Veterans and providers.
Quantitative analyses will describe and compare Veterans’ health services use, mortality and costs. Qualitative
analyses will focus on understanding how perceived attributes of the CCNA tools, as well the perceived
organizational context and implementation, influence uptake and adoption. The results of these analyses will
inform ongoing CCNA adaptation, build the evidence for the utility of the innovation attributes for real-life
implementation, and ensure evaluation of CCNA tools captures the most important elements.
Next Steps/Implementation/Sustainability: Building the evidence for care coordination processes will inform
best practices and implementation. With the VA’s electronic health record migration, this study may inform how
to adapt new CCNA electronic tools to facilitate and sustain implementation of evidenced-based practices.

Public health relevance
Implementation of effective care coordination practices are a high priority for the VA and is the focus of two major national initiatives to address MISSION Act access to care goals. Prior research suggests enhancement of care coordination can improve appropriate access and outcomes, especially for complex, chronic care patients. In the VA, care coordination assessment and services vary across sites and evidence is lacking on whether Veterans who need the services receive them, and the extent to which they benefit when received. We will be guided by organizational theory and apply multiple methods in an observational study with a comparison group. Using routinely collected care coordination needs assessment data, supplemented with Veteran health care use data, and Veteran and provider perspectives, we will evaluate care coordination needs assessment tools and practices and their impacts on Veteran health care use, outcomes and costs.